Interdisciplinary Training Program in Immunology

PROJECT SUMMARY: The Interdisciplinary Training Program in Immunology (ITPI), currently in its 45th year
of funding, represents the primary support for graduate students in Immunology at the University of Chicago.
The program is embodied by the Committee on Immunology, an interdisciplinary and interdepartmental
academic unit that serves as the scientific community for immunology graduate students, postdocs, and faculty
at the University. The ITPI supports eight training slots and features 34 distinguished faculty selected for their
outstanding research and training records, their well-funded laboratories, and their dynamic involvement in all
aspects of graduate education. Their research spans a broad spectrum of modern areas of immunology including
cellular and molecular immunology, biochemistry, genomics, and microbiome studies, with a proven record of
interdisciplinary collaborations. New strength stems from the recent implementation of the Computational &
Systems Immunology (CSI) specialty track for Immunology trainees seeking the advanced conceptual and
technical training needed to tackle immunological questions using quantitative and systems-level genomic
approaches. This initiative is buoyed by our recent recruitment of eight junior faculty who are emerging leaders
in three priority areas, including CSI, human immunology, and molecular engineering, as well as the development
of two new specialized graduate courses in data sciences tailored specifically for Immunology trainees. All
students in the ITPI receive advanced training through courses focused on the critical analysis of primary
literature and experimental design, with special emphasis on bioinformatics skills, rigor and reproducibility, and
the responsible conduct of research. The comprehensive training includes a weekly Seminar Series, Work-in-
Progress forum, and Journal Club, as well as unique scientific events such as the Joint Immunology Retreat and
the T32 Career Perspectives in Immunology virtual event, which both stem from a joint partnership with
Washington University in St. Louis. Career development is enhanced through MyChoice, an institutional program
enabling trainees to further develop academic skills and gain exposure to a broad array of research-intensive
career paths. The Biological Sciences Division provides strong institutional support, as shown by sustained
financial and administrative support, the operation of cutting-edge core facilities, and the implementation of major
initiatives such as the Duchossois Family Institute, which aims to harness the power of the microbiome and
immunity for human health. The ITPI is continuously and rigorously evaluated with respect to organization,
process, objectives, and outcomes. This is one of the most outstanding and competitive training programs in the
country, as shown by the diverse nature of the student body, the high retention and completion rates of our
trainees, their impressive publication record (average of five publications per trainee, including many first-author
publications in high-impact journals (IF>20), and their success in securing independent careers in research-
intensive and research-related areas.

Public health relevance
PROJECT NARRATIVE: This program trains the next generation of immunologists who will lead the innovative research, teaching, and biomedical entrepreneurship that is needed to advance basic science and develop new translational approaches for the prevention and treatment of autoimmune diseases and cancer, the improvement of organ transplantation, and the design of new and more effective vaccines. The funding will contribute to public health by supporting the training of highly skilled individuals who will join the national biomedical research workforce.